Diversity Supplement on "1/2 Treating Mothers with ADHD and their Young Children Via Telehealth: A Hybrid Type I Effectiveness-Implementation Trial"

Project Summary
The applicant will gain research and experience by participating in clinic recruitment efforts and screening
participants. Through literature review and stakeholder interviews, she will identify cultural, logistic, and
communication barriers to recruitment and retention in ADHD clinical research, and (2) identify BIPOC
community-led solutions to increase representation in research. This information will then be provided to the
research team. During this year long experience, she will receive mentoring from Drs. Stein, Lion, and Bennett
and participate in a variety community, clinical, and professional experiences to prepare for a future career in
medicine.

Public health relevance
Project Narrative This Diversity Supplement proposal advances the parent grant entitled “Treating Parents with ADHD and their Young Children via Telehealth: A Hybrid Type 1 Effectiveness-Implementation Trial R01MH118313 (TPAC study) by identifying and modifying barriers to recruitment of BIPOC (Black, indigenous, people of color) individuals.